GERIATRIC LEADERSHIP ACADEMIC AWARD

This is an application for renewal of a Geriatrics Leadership Academic Award. The candidate proposes to enhance aging research at the University of Pennsylvania by continuing his activities in: (1) organizing and promoting collaborative research projects, (20 developing research training programs, (30 developing a multidisciplinary pilot research project program, (4) developing resources in aging, especially an aging animal resource, (5) developing additional educational projects which will ultimately enhance research, and (6) by expanding his own breadth in gerontology and geriatrics.